Skeletal development and the hematopoietic niche

DESCRIPTION (provided by applicant): Certain immuno-osseous and hematopoietic disorders likely result from an impaired hematopoietic niche, which in turn may ensue from defective endochondral ossification (EO), where a cartilage skeletal blueprint is replaced by trabecular bone and marrow. This proposal will test our hypothesis that the EO- derived chondro-osseous junction (COJ), comprised of hypertrophic cartilage and trabecular bone, is a key hematopoietic niche within the marrow. This hypothesis stems from our transgenic (Tg) and null mice for collagen X, a matrix protein expressed in hypertrophic cartilage prior to EO. Mice with disrupted collagen X function display skeleto-hematopoietic defects including altered hypertrophic cartilage and trabecular bone in the COJ, marrow hypoplasia, diminished lymphopoiesis, and impaired immune function. We propose that these defects stem from an altered hematopoietic niche within the COJ, and that these mice provide an innovative system to identify the mechanistic basis for niche-mediated disorders. The goals of this proposal are to implicate a subset of COJ progenitors and collagen X as key regulators of the hematopoietic niche by: 1) Assessing by bone marrow transplantation if all hematopoietic defects in the collagen X mice could be attributed to niche impairment and whether homing of transplanted HSCs to the COJ niche could be visualized via two-photon microscopy; 2) Testing the ability of EO-progenitors from control and collagen X mice to reconstitute an ectopic COJ and HSC niche upon transplantation; and 3) Determining if EO-derived osteoprogenitors require collagen X for niche establishment and/or niche maintenance.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal will test if the environment or "niche" in the marrow where blood cells form, is generated by a skeletal development process. We will use genetically engineered mice that have a niche defect to identify the skeletal components needed for proper formation and function of the blood cell niche. Data should yield insights into basic stem cell biology, as well as aid in diagnosis and treatment of niche-mediated diseases. This proposal will test if the environment or "niche" in the marrow where blood cells form, is generated by a skeletal development process. We will use genetically engineered mice that have a niche defect to identify the skeletal components needed for proper formation and function of the blood cell niche. Data should yield insights into basic stem cell biology, as well as aid in diagnosis and treatment of niche-mediated diseases. __SpecificAimsTextDelimiter__ Program Director/Principal Investigator (Last, First, Middle): Jacenko, Olena 2. Specific Aims: The recently appreciated reciprocal regulation of the skeletal and immune systems has led to a new field of study, osteoimmunology. In particular, factors produced by immune cells markedly affect the skeleton, and bone provides essential niches for lymphocyte development11. Indeed, some immuno-osseous disorders, hematopoietic defects such as bone marrow failure and immune dysfunction, as well as certain cancers likely result from a defective hematopoietic niche6,7, which in turn may ensue from a skeletal defect. Likewise, hematopoietic aging, characterized by altered blood cell differentiation, deficient immune function and increased incidence of malignancies, may ensue from niche aging12. Understanding how hematopoietic niches are established, how they promote hematopoiesis, and how the skeletal status modulates niche function, should provide therapeutic strategies for diseases, as well as aging changes, that affect either or both systems. The coordinate development of the skeleto-hematopoietic systems represents a long-standing focus of our laboratory, and stems from our studies on collagen X transgenic (Tg) and null (KO) mice1,13,14. In these mice, the function of collagen X, a major hypertrophic cartilage matrix protein is disrupted during endochondral ossification (EO), a skeletogenesis mechanism where a cartilage matrix supports the formation of trabecular bone and a hematopoietic marrow. ALL mice with disrupted collagen X function display aberrant EO-derived tissues and altered hematopoietic development. Specifically, these mice form abnormal hypertrophic cartilage and trabecular bone in the chondro-osseous junction (COJ), which is the interface between skeletal tissue and marrow where hematopoietic stem cell (HSCs) likely reside15,16. Further, all mice display suppressed marrow lymphopoiesis and impaired immune function throughout life1,8, 9,13,17,18,19,20. Our recent data indicate that the hematopoietic defects stem from disruption of collagen X in the COJ9. In this proposal, the collagen X mice will provide a means to assess the impact of COJ-disruption on hematopoiesis, and to identify the cell and matrix constituents of the hematopoietic niche. Specifically, over 5 years, 3 Aims will test our hypothesis that the COJ, comprised of an EO-derived and collagen X-containing hypertrophic cartilage and trabecular bone, is a key hematopoietic niche. Aim 1. To test by neonatal bone marrow transplantation (N-BMT) that an impaired niche is solely responsible for all hematopoietic and immune defects in the collagen X mice, and to visualize the niche within the COJ following N-BMT by time-lapse intravital imaging. We hypothesize that the collagen X- containing COJ harbors the hematopoietic niche. Our preliminary data support this by demonstrating that N- BMT of control cells into collagen X-deficient neonatal recipients recapitulates the hematopoietic disease phenotype. In Aim 1A We will use reciprocal N-BMT to directly test if the altered hematopoietic profile and impaired immune function observed in the collagen X mice can be solely ascribed to an altered niche in the COJ as predicted, or if an HSC defect may also contribute to components of this phenotype. In Aim 1B, we will use in vivo imaging by 2-photon microscopy to compare localization of labeled blood cell progenitors/HSCs to the COJs of control vs. collagen X-deficient mice post N-BMT. We predict that HSCs and hematopoietic cells will localize along trabecular bone surfaces within the COJ of control mice, whereas in the collagen X-deficient mice, hematopoietic cell localization will be altered due to a defective COJ. Aim 2. To test by in vivo cell transplantation whether EO-derived cells are both sufficient and necessary for establishment of an ectopic hematopoietic niche within a COJ. Others have shown that EO-derived progenitor cells can form bone with a marrow ectopically21-23, and our hypothesis would suggest that a properly functioning COJ is necessary for this process. Thus, we predict that EO-derived COJ progenitor cells would be sufficient to reconstitute an ectopic niche, however EO-progenitors from collagen X KO mice will be unable to establish a COJ supportive of hematopoiesis due to the requirement of these cells and their collagen X matrix for proper niche function. We will thus adapt a recently established in vivo cell transplantation assay21-23 to assess the ability of EO-progenitor cells from control and collagen X KO mice to undergo EO progression, COJ formation, marrow establishment, and to support hematopoiesis. Graft-HSC function will be further evaluated by explant bone marrow transplantation (E-BMT). Aim 3. To determine if EO-derived progenitors require collagen X for niche establishment and/or niche maintenance. We hypothesize that EO-derived trabecular osteoblasts constitute the hematopoietic niche cells and that they require collagen X for niche establishment. We will test this in Aim 3A by inactivating collagen X in the osterix-expressing24 subset of hypertrophic chondrocytes and osteoprogenitors and assessing the resultant mice for hematopoietic and immune defects. In Aim 3B we will inactivate collagen X after the COJ is established in both juvenile and adult mice through use of a recently generated tamoxifen- inducible Collagen X promoter mouse, and will thus test the effects of collagen X absence on niche maintenance by assessing hematopoietic function. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page